4/4: The INTEGRATE Study: Evaluating INTEGRATEd care to Improve Biopsychosocial Outcomes of Early Liver Transplant for Alcohol-Associated Liver Disease

PROJECT SUMMARY
Alcohol-associated liver disease (ALD), which includes alcohol-associated cirrhosis (AAC) and alcohol-
associated hepatitis (AH), is now the leading indication for liver transplant (LT) in the US. Early LT (eLT),
defined as LT evaluation with <6 months of alcohol abstinence, is associated with acceptable outcomes for AH
in retrospective studies. However, prospective, multi-center data including biopsychosocial factors on eLT for
all advanced ALD in racially, culturally, and socioeconomically diverse populations are lacking. It is known that
alcohol cessation is the most important factor influencing survival in ALD, and integrated alcohol use disorder
(AUD)/ALD care is critical to help patients achieve abstinence, yet the degree of care integration and how this
influences post-LT outcomes has not been systematically studied. Knowledge gaps in eLT for ALD include: a)
limited data on who gets referred for eLT and referral barriers; b) lack of standardized biopsychosocial
measures and outcomes; and c) minimal stakeholder involvement beyond LT providers. There is an urgent
need to (1) define factors influencing eLT referral, (2) develop risk prediction models of key patient-centered
outcomes, (3) incorporate validated biopsychosocial measures into models, and (4) evaluate the impact of
integrated care on outcomes following eLT. For example, The INTEGRATE collaborative, comprised of
diverse, multidisciplinary clinicians and researchers from the University of Texas Southwestern Medical Center,
University of Michigan, University of Miami, and Columbia University-Weill Cornell Medicine, is ideally
positioned to address these urgent research needs. Collectively, we have developed a distinctive investigator
team with diversity in: (1) career stage (2) sex and race/ethnicity, (3) clinical and methodological expertise in
ALD, AUD, LT, behavioral research, risk modeling, data harmonization, health disparities, causal inference,
and mixed-methods research, and (4) documented track record of NIH funding in LT access, organ allocation,
LT outcomes and healthcare disparities, and NIAAA funding in ALD/AUD. Our large volume transplant centers
with established protocols for eLT for ALD applied to highly diverse populations will facilitate the following aims:
1) characterize and develop risk prediction models for transplant-free survival among those with limited access
to LT to define those in greatest need of eLT referral and listing; 2) evaluate barriers and facilitators to referral
for eLT in ALD; 3) apply causal inference approaches to observational data to evaluate biopsychosocial factors
and develop risk models predictive of outcomes at key timepoints in eLT for ALD; 4) define stakeholder
perceptions and preferences for selection and outcomes in eLT for ALD; and 5) evaluate how integrated care
processes influence outcomes in eLT for ALD. At the conclusion of this work, we will have collaboratively: (1)
defined factors for referral and waitlisting for eLT in ALD (selection), (2) identified which biopsychosocial
factors are causally related and predictive of outcomes most important to stakeholders (outcomes) and (3)
determined how integrated care influences stakeholder-relevant outcomes in eLT for ALD (management).

Public health relevance
PROJECT NARRATIVE Early liver transplantation (eLT), defined as LT evaluation with <6 months of alcohol abstinence, is associated with acceptable outcomes for patients with severe alcohol-associated liver disease (ALD) in retrospective studies. However, prospective, multi-center data including biopsychosocial factors on eLT for all patients with ALD in racially, culturally, and socioeconomically diverse populations are lacking. The INTEGRATE collaborative is a highly diverse investigative team that seeks to: 1) define factors influencing referral and waitlisting for eLT in ALD (selection); 2) identify which biopsychosocial factors are causally related and predictive of outcomes most important to stakeholders (outcomes); and 3) determine how integrated care among the healthcare team influences stakeholder-relevant outcomes in eLT for ALD (management).